Characterizing variation and adaptation in the immune response to plague (Y. pestis) through single-cell sequencing and ancient genomics

PROJECT SUMMARY
Pathogens have been one of the strongest selective pressures in human evolution. Migrating out of Africa,
modern humans encountered novel pathogens along with new environments. These populations likely adapted
to these pathogens, leading to population-specific adaptations. Consistent with this hypothesis, some of the most
compelling signatures of local adaptation in the human genome overlap genes involved in immunity and host
defense. Importantly, these regions also overlap genetic loci which are associated with infectious, autoimmune,
and inflammatory disease risk in modern humans. Thus, understanding adaptation to pathogens throughout
history is important for understanding modern human health.
The Black Plague was likely one of the strongest selective events in recent human history. Exposure to
Yersinia pestis (the causative agent of plague) therefore likely drove adaptations in the human immune system
which continue to shape modern immune variation. Importantly, because the plague ravaged Eurasia while
leaving sub-Saharan Africa relatively untouched, adaptation to plague likely occurred in European but not African
populations. However, it is not known whether human populations differ in their immune response to plague as
a consequence of prior evolutionary history. Addressing this gap is not only important for understanding the
recent evolution of the human immune system, but may also help reveal the molecular basis of ancestry-related
differences in susceptibility to infectious disease, chronic inflammation, and autoimmune disorders.
The basic research questions driving this proposal are: What was the impact of Y. pestis to the functional
differentiation of immune responses between African- and European-ancestry individuals? To which extent
natural selection has favored the increase in frequency of protective alleles in Europeans, a population with
increased exposure to Y. pestis? What cell types and immunological pathways show the most divergence in
response to Y. pestis between populations? To answer this questions, I will experimentally infected peripheral
blood cells in culture to characterize the immune response to plague. Using single-cell RNA sequencing I will be
able to analyze variation in the immune response across cell types, but also characterize differences in the
proportion of cells responding to infection and the strength of that response. Using this data, I will identify genes
and pathways which are regulated differently in individuals of European and African ancestry, and
identify genetic variants which contribute to these differences. I will then use a combination of ancient and
modern genomics to test whether loci underlying variation in the immune response to Y. pestis also experienced
position selection during the Black Plague. Thus, this project is a novel integration of functional and population
genetic approaches to study adaptation to a deadly human pathogen. At its conclusion, this study will reveal how
Europeans adapted to Y. pestis exposure during the plague, and identify highly-promising genetic candidates
which may contribute to disease susceptibility in modern human populations.

Public health relevance
PROJECT NARRATIVE The Black Plague, caused by the bacteria Yersinia pestis, is arguably the strongest selective event in recent human history. Here, I seek to characterize the immune response to Y. pestis and identify genomic signatures of adaptation to the plague in Europeans through a novel combination of single-cell RNA sequencing of infected cells and ancient genome sequencing on individuals living prior to and after the Black Plague. This project will be the first to link a human pathogen with specific evolutionary changes, and will likely yield additional insights into the mechanisms which underlie health disparities between human populations.